A Phase Ia/Ib Clinical Study of HIV Entry Inhibitor CPT31:Single and Multiple Ascending Dose Study of Safety, Tolerability, Pharmacokinetics, and Pharmacodynamics in Healthy Adults anAdults with HIV

SUMMARY
HIV/AIDS remains a formidable global epidemic, with ~37 million people infected (including ~1.1 million in
the US) and about one million AIDS-­related deaths in 2017 (UNAIDS, CDC). Despite the efficacy of modern
combination anti-­retroviral therapy (cART), side effects and drug resistance remain serious obstacles to
achieving optimal care, and poor adherence is a key factor in treatment failure. Thus, there is continued
demand for well-­tolerated HIV inhibitors with novel mechanisms of action and stronger barriers to resistance.
HIV specialists are especially enthusiastic about the potential of long-­acting therapies to minimize side effects,
enhance efficacy, and delay resistance through improved compliance. Navigen has identified a novel,
protease-­resistant D-­peptide HIV entry inhibitor, CPT31, with these desired characteristics and has advanced it
through preclinical development. CPT31 addresses many of the limitations of current cART and has proven to
be well tolerated and highly efficacious for both indications in non-­human primates (NHPs), making it an ideal
candidate for both therapy and PrEP. Additionally, CPT31’s PK makes it amenable to monthly and perhaps
quarterly dosing (with depot formulation). In this grant application, we will partner with Johns Hopkins
University to conduct a Phase Ia/Ib safety, tolerability, pharmacokinetics, and pharmacodynamics study of
CPT31. The study will include three stages: 1) single ascending dose (SAD) in healthy volunteers, 2) multiple
ascending dose (MAD) in healthy volunteers, and 3) MAD in HIV positive patients classified as Group 1 under
the FDA guidance for industry. This study will enable Navigen to determine whether CPT31 has the
characteristics that warrant continued clinical studies and further investment.

Public health relevance
NARRATIVE Despite the efficacy of modern combination anti- retroviral therapy (cART) for HIV, side effects and drug resistance remain serious obstacles to achieving optimal care. Navigen’s novel, protease- resistant D- peptide HIV entry inhibitor, CPT31, addresses many of the limitations of current cART and is well- tolerated and highly efficacious in non- human primates. In this grant application, we will partner with Johns Hopkins University to conduct a Phase Ia/Ib safety, tolerability, pharmacokinetics, and pharmacodynamics study of CPT31.